OUTREACH: Opioid Use TReatment via telehEAlth in CHCs

Improving access to opioid use disorder (OUD) treatment is critical to curb opioid overdose rates in the United States. Alarmingly, only 25% of adults with an OUD receive opioid agonist or antagonist treatment. In March of 2020, telehealth policies were enacted to increase access to OUD treatment, including federal regulatory agencies authorizing remote buprenorphine induction and prescription refills if a patient could be adequately evaluated and monitored via telehealth. Many insurers began reimbursing at the same rate for in-person, video and telephone visits. Prior to telehealth implementation, access and utilization of primary care-based OUD treatment were limited. Expansion of telehealth promoted access to OUD care that might not have been accessible otherwise and has the potential to reach patients with low rates of in-person primary care-based OUD treatment. Conversely, limited access to technology and low digital literacy could hinder the use of telehealth services in some populations (e.g., older adults, those living in rural areas). While telehealth has been shown to be as effective as in-person care in engaging and retaining patients on medications for opioid use disorder (MOUD), most studies were conducted within a few years of policy implementation. Significant gaps remain in our knowledge of how these changes have affected rates of and characteristics associated with OUD care as telehealth has evolved within health care settings and become a standard option for care delivery. Moreover, little is known about the patterns of telephone, video and in-person visits for OUD care over time or the multi-level characteristics associated with use of each modality. To date, no studies have comprehensively evaluated the impact of telehealth expansion on OUD care within community health centers (CHCs) which are at the forefront of the opioid epidemic. Our study uses almost a decade of CHC electronic health record (EHR) data (N>3.6 million patients in 35 states) from OCHIN, one of the nation’s largest safety-net networks with a single EHR. The data set includes over 90,000 patients with an OUD diagnosis, of whom more than 40% had an order for an MOUD. We link the EHR data set with community-level data and Datavant mortality data to: 1) Examine rates of OUD-related care (e.g., OUD diagnosis, MOUD orders, MOUD retention, behavioral health) in CHCs before, during, and after telehealth expansion; 2) Examine rates of OUD-related care in CHCs by visit modality (in-person, video, telephone) over time; and 3) Identify patient- and community-level factors that moderate the associations between visit modality and OUD care over time. This study uses a robust linked data set to conduct a comprehensive and rigorous examination of changes in the rates and moderators of OUD care among CHC patients seen before, during, and after the expansion of telehealth. Our evaluation informs future telehealth policy decisions and clinical guidelines, and determines what, if any, interventions are warranted within CHC settings to ensure access to OUD treatment for all individuals in need.

Public health relevance
Changes in telehealth policies for care delivery have the potential to increase access to primary care-based treatment for opioid use disorder, which is critical to reducing opioid overdose rates. This study uses data from a large network of community health centers (CHCs) to 1) examine rates of opioid use disorder care before, during, and after telehealth expansion, 2) examine rates of opioid use disorder care by visit modality (in-person, telephone, video) over time, and 3) identify patient- and community-level factors that moderate the associations between visit modality and opioid use disorder care over time. Study findings are critical to informing future federal, state and local telehealth policies and clinical guidelines related to opioid use disorder care, and to determining if interventions are needed within CHC settings to ensure access to treatment for all individuals in need. References 1. Uscher-Pines L, Riedel LE, Mehrotra A, Rose S, Busch AB, Huskamp HA. Many Clinicians Implement Digital Equity Strategies To Treat Opioid Use Disorder. Health Aff (Millwood). Feb 2023;42(2):182-186. doi:10.1377/hlthaff.2022.00803 2. The American Society of Addiction Medicine. COVID-19-Ensuring Access to Care in Opioid Treatment Programs. Accessed September 4, 2023. https://www.asam.org/quality-care/clinical-recommendations/covid/access-to-care-in-opioid-treatment-program 3. Chu RC PC, De Lew N, Sommers BD,. State Medicaid Telehealth Policies Before and During the COVID-19 Public Health Emergency. Vol. HP-2021-17. Issue Brief. July 2021. 4. Stein BD, Dick AW, Sorbero M, et al. A population-based examination of trends and disparities in medication treatment for opioid use disorders among Medicaid enrollees. Subst Abus. 2018/10/02 2018;39(4):419-425. doi:10.1080/08897077.2018.1449166 5. Kilaru AS, Xiong A, Lowenstein M, et al. Incidence of Treatment for Opioid Use Disorder Following Nonfatal Overdose in Commercially Insured Patients. JAMA Netw Open. May 1 2020;3(5):e205852. doi:10.1001/jamanetworkopen.2020.5852 6. Anastos-Wallen RE, Mitra N, Coburn BW, et al. Primary Care Appointment Completion Rates and Telemedicine Utilization Among Black and Non-Black Patients from 2019 to 2020. Telemed J E Health. Dec 2022;28(12):1786-1795. doi:10.1089/tmj.2022.0104 7. National Academies of Sciences Engineering and Medicine. Medications for Opioid Use Disorder Save Lives. National Academies Press Accessed September 2, 2023. https://www.nap.edu/catalog/25310/medications-for-opioid-use-disorder-save-lives 8. Dowell D, Brown S, Gyawali S, et al. Treatment for Opioid Use Disorder: Population Estimates - United States, 2022. MMWR Morb Mortal Wkly Rep. Jun 27 2024;73(25):567-574. doi:10.15585/mmwr.mm7325a1 9. Lythreatis S, Singh SK, El-Kassar A-N. The digital divide: A review and future research agenda. Technological Forecasting and Social Change. 2022/02/01/ 2022;175:121359. doi:https://doi.org/10.1016/j.techfore.2021.121359 10. National Institute on Drug Abuse. 2022-2026 NIDA Stategic Plan: Director’s Message. September 20 2022. Accessed May 20, 2025. https://nida.nih.gov/about-nida/2022-2026-strategic-plan/directors-message 11. Tilhou AS, Dague L, Saloner B, Beemon D, Burns M. Trends in Engagement With Opioid Use Disorder Treatment Among Medicaid Beneficiaries During the COVID-19 Pandemic. JAMA Health Forum. Mar 2022;3(3):e220093. doi:10.1001/jamahealthforum.2022.0093 12. Jones CM, Shoff C, Hodges K, et al. Receipt of Telehealth Services, Receipt and Retention of Medications for Opioid Use Disorder, and Medically Treated Overdose Among Medicare Beneficiaries Before and During the COVID-19 Pandemic. JAMA Psychiatry. Oct 1 2022;79(10):981-992. doi:10.1001/jamapsychiatry.2022.2284 13. Mahmoud H, Naal H, Whaibeh E, Smith A. Telehealth-Based Delivery of Medication-Assisted Treatment for Opioid Use Disorder: a Critical Review of Recent Developments. Curr Psychiatry Rep. Sep 2022;24(9):375-386. doi:10.1007/s11920-022-01346-z 14. Wunsch C, Wightman R, Pratty C, et al. Thirty-day Treatment Continuation After Audio-only Buprenorphine Telehealth Initiation. Journal of Addiction Medicine. 9900; 15. Palzes VA, Chi FW, Metz VE, et al. Overall and Telehealth Addiction Treatment Utilization by Age, Race, Ethnicity, and Socioeconomic Status in California After COVID-19 Policy Changes. JAMA Health Forum. May 5 2023;4(5):e231018. doi:10.1001/jamahealthforum.2023.1018 16. Mark TL, Treiman K, Padwa H, Henretty K, Tzeng J, Gilbert M. Addiction Treatment and Telehealth: Review of Efficacy and Provider Insights During the COVID-19 Pandemic. Psychiatr Serv. May 2022;73(5):484-491. doi:10.1176/appi.ps.202100088 17. Austin AE, Tang L, Kim JY, et al. Trends in Use of Medication to Treat Opioid Use Disorder During the COVID-19 Pandemic in 10 State Medicaid Programs. JAMA Health Forum. Jun 2 2023;4(6):e231422. doi:10.1001/jamahealthforum.2023.1422 18. Nguyen B, Zhao C, Bailly E, Chi W. Telehealth Initiation of Buprenorphine for Opioid Use Disorder: Patient Characteristics and Outcomes. J Gen Intern Med. Jan 2024;39(1):95-102. doi:10.1007/s11606-023-08383-1 19. Hatef E, Wilson RF, Zhang A, et al. Effectiveness of telehealth versus in-person care during the COVID-19 pandemic: a systematic review. NPJ Digit Med. Jun 15 2024;7(1):157. doi:10.1038/s41746-024-01152-2 20. Patel SY, Ortiz EG, Barsky BA, Huskamp HA, Busch AB, Mehrotra A. Patient and Clinician Characteristics Associated with Use of Telemedicine for Buprenorphine Induction Among Medicare Beneficiaries. J Gen Intern Med. Nov 2022;37(14):3758-3761. doi:10.1007/s11606-022-07633-y 21. Lin LA, Zhang L, Kim HM, Frost MC. Impact of COVID-19 Telehealth Policy Changes on Buprenorphine Treatment for Opioid Use Disorder. Am J Psychiatry. Jul 28 2022:appiajp21111141. doi:10.1176/appi.ajp.21111141 22. Frost MC, Zhang L, Kim HM, Lin LA. Use of and Retention on Video, Telephone, and In-Person Buprenorphine Treatment for Opioid Use Disorder During the COVID-19 Pandemic. JAMA Netw Open. Oct 3 2022;5(10):e2236298. doi:10.1001/jamanetworkopen.2022.36298 23. Bailey SR, Wyte-Lake T, Lucas JA, et al. Use of Telehealth for Opioid Use Disorder Treatment in Safety Net Primary Care Settings: A Mixed-Methods Study. Subst Use Misuse. 2023;58(9):1143-1151. doi:10.1080/10826084.2023.2212378 24. Kaiser Family Foundation. The Role of Community Health Centers in Addressing the Opioid Epidemic. Accessed May 20, 2025. https://www.kff.org/medicaid/issue-brief/the-role-of-community-health-centers-in-addressing-the-opioid-epidemic/ 25. Center for Health Care Strategies. Federally Qualified Health Centers Can Help Address the Opioid Crisis. Accessed February 8, 2024. https://www.chcs.org/federally-qualified-health-centers-can-help-address-the-opioid-crisis/#:~:text=In%20recent%20years%2C%20FQHCs%20have,help%20expand%20access%20to%20treatment. 26. National Association of Community Health Centers. Community Health Center 2024 Chartbook. Accessed June 21, 2024. https://www.nachc.org/wp-content/uploads/2023/07/Community-Health-Center-Chartbook-2023-2021UDS.pdf